MICROTUBULE CHANGES IN SUT CELL W/ TAXOL &CYCLOSPORIN: DRUG RESIST, LUNG CANCER

Drug resistance is the greatest obstacle to sucessful treatment of human lung cancer, the leading cause of cancer death among men and women in the United States. Cyclosporin A has been used in preclinical and a few early clinical studies to overcome multi-drug resistance. We have shown that sensitivity to paclitaxel in non-resistant cell lines can be enhanced by CsA despite lack of expression of classical drug resistance pumps. We are using CATS and immuno-fluorescence staining to visualize microtubule assembly in cells incubated with paclitaxel and CsA. Microtubule assembly dynamics will be explored using fluorescence spectroscopy.